Predicting phenotypes in benign urology

PROJECT SUMMARY
When patients present with urinary urgency, frequency and nocturia, with or without
urgency incontinence, we consider this the clinical phenotype of overactive bladder (OAB).
Clinical observations and data suggest that clinical OAB may be comprised of several underlying
subtypes. Discerning between subtypes has been challenging but is imperative to precisely
guide targeted treatments.
Within the last decade, several large observational cohort studies have been developed
with the goal of improving our understanding of the pathophysiology underlying benign
urologic symptom disorders. The NIDDK-sponsored Multidisciplinary Approach to the Study of
Pelvic Pain (MAPP) network and Lower Urinary Tract Dysfunction Research Network (LURN)
have collected data on urologic pain syndromes and non-painful lower urinary tract symptoms
(LUTS), respectively. Both cohorts included patients with OAB. To identify clinically meaningful
subtypes, MAPP and LURN used clustering methods to mathematically classify patients into
probable subtypes using clinical characteristics. Though biospecimens were collected in both
cohorts, biologic data from these specimens were not included in clustering. If OAB subtypes
have different pathophysiology, biologic data are likely to add important distinguishing
information, and possibly be predictive of differential treatment responses.
Based on clinical observations and prior clustering work, we hypothesize that the syndrome
of idiopathic OAB is comprised of 5 phenotypic subtypes, including dysbiotic and metabolic
subtypes that will have distinct microbiome profiles from the others. To test our hypotheses,
we propose an innovative approach combining MAPP and LURN clinical datasets and already
collected biospecimens. Since sex-specific factors may affect subtypes, analyses will be
performed on females and males separately.
Our current “one-size fits all” algorithm of OAB treatments results in repeated medical
visits, high health-care costs, and marginal long-term effectiveness. There is a major gap in
knowledge of OAB subtypes, which in turn hampers our ability to target treatments to
subgroups where they would be most effective. The proposed analyses by experienced data
scientists present a unique opportunity to leverage existing resources from well-defined
prospective clinical cohorts to substantially enhance our understanding of OAB.

Public health relevance
PROJECT NARRATIVE Overactive bladder (OAB) is an extremely common symptom complex that is challenging to treat clinically due to several underlying etiologies. This proposal seeks to elucidate OAB subtypes utilizing comprehensive clinical and demographic data from two NIDDK-funded consortia networks and to further identify if the addition of microbiome characteristics aids in defining OAB subtypes. We additionally will determine if stratification by OAB subtype improves predicted response to OAB treatment.